Discovering mechanisms of neuroblastoma tumorigenesis to improve patient outcomes

PROJECT SUMMARY
After stunning improvements in patient outcomes for most childhood cancers in the latter half of the last century,
cure rates have since plateaued, and treatment related morbidity continues to mount. Children with metastatic
solid malignancies continue to have a less than 50% chance of survival despite being treated with highly intensive
cytotoxic therapies. Neuroblastoma, a diverse malignancy typically affecting very young children that arises from
the developing sympathetic nervous system, is responsible for a disproportionate amount of morbidity and
mortality attributable to childhood cancer and is the main focus of this R35. Our primary motivation in this
competitive renewal application is to improve patient outcomes, and we also deem neuroblastoma an
outstanding model of cancer in general, such that discoveries of basic mechanisms of tumorigenesis are broadly
applicable to other human malignancies. Over the next seven years, we will continue to seek to substantively
improve cure rates for patients through a multidisciplinary and collaborative research program. Our broad goal
is to discover the fundamental mechanisms that subvert normal neuronal development and orchestrate
neuroblastoma tumorigenesis, and then to translate this knowledge into patient-specific therapies that will be
more effective and less toxic. We thus propose to expand on our comprehensive approach to discover and
develop novel therapeutic strategies for patients with high-risk neuroblastoma and other childhood cancers. We
will build on progress in the current R35 and address genomic vulnerabilities with precision therapies with a
focus on novel immunotherapies. Having developed methods to identify exquisitely tumor specific
immunotherapeutic targets, we will create synthetic immunotherapies including antibodies, antibody drug
conjugates, bi-specific T cell engagers, and chimeric antigen receptor (CAR) T cells. With several of the therapies
created in the current R35 having entered clinical trials recently and throughout the next seven years, we have
a unique opportunity to have robust correlative biology to guide our evolving armamentarium of therapeutics. We
will enhance the efficacy and persistence of CAR T cells with through both T cell intrinsic (enhancing metabolic
fitness) and extrinsic (vaccination to provide an antigenic stimulus) methods. While the current R35 focused
almost exclusively on neuroblastoma, we have recently extended our immunotherapy target discovery efforts to
other childhood cancers with a high unmet need, and this will be expanded moving forward through both new
discovery efforts and the rigorous definition of biomarkers for immunotherapeutic selection across childhood
cancers. We think that our research program proposes a variety of innovative experimental strategies to uncover
basic mechanisms of oncogenesis, epigenetic adaptation, and immune evasion. This R35 is and will remain
steadfastly translational. The significance of the proposed program is the discovery of fundamental mechanisms
of tumorigenesis that will lead to new therapies with markedly improved probability of cure coupled with reduced
morbidity for children, adolescents, and young adults with neuroblastoma and other childhood cancers.

Public health relevance
PROJECT NARRATIVE The research program proposed here is relevant to public health because it seeks to discover fundamental principles of cancer etiology, evolution, and response to therapy, focusing on the childhood malignancy neuroblastoma. The research is highly relevant to the NIH mission and the urgent unmet need of developing rational evidence-based therapeutic strategies to reduce the health burden of cancer. This R35 is designed to discover the basic oncogenic mechanisms of high-risk neuroblastoma that are amendable to novel therapeutic strategies designed to dramatically and safely improve patient outcomes.